IMMUNOTHERAPY FOR CHILDHOOD ASTHMA

The study examines the effectiveness of optimal allergen immunotherapy for perennial asthma in atopic children on 1) the severity and course of asthma, and 2) the natural history of non-specific airway hyperactivity.